PATHOGENESIS AND PATHOPHYSIOLOGY OF FAMILIAL NEUROHYPOPHYSEAL DIABETES

This project is part of an ongoing study to define the pathogenesis and pathophysiology of the autosomal dominant form of familial neurohypophyseal diabetes insipidus (FNDI). In the last 4 years, we and others have determined that FNDI is linked to diverse mutations in the coding region of the gene for the polypeptide precursor (AVP-NPII). We postulate that FNDI is due to selective destruction of AVP-producing neurohypophyseal neurons by a mutant precursor that gradually accumulates and disrupts the cells because it cannot be processed properly.